Free fatty acid receptor 4 cardioprotective effects in cardiac ischemic injury

Coronary heart disease (CHD), leading to myocardial infarction (MI) and post-­MI heart failure (HF), is a
major cause of morbidity and mortality in the US. w3-­polyunsaturated fatty acids, like eicosapentaenoic acid
(EPA), improve outcomes in CHD and HF, but this is controversial. First, several trials with low-­dose w3s have
failed, but recent trials with high-­dose w3s (REDUCE-­IT, OMEGA-­REMODEL) report improved outcomes.
Second, the mechanism of w3-­cardioprotection is unclear, but free fatty acid receptor 4 (Ffar4), a GPCR for
long-­chain fatty acids, is a novel mechanism to explain w3-­cardioprotection. In mice, we were the first to
establish that EPA prevents cardiac fibrosis and contractile dysfunction in pressure overload. Yet, EPA was not
incorporated into cardiac myocytes or fibroblasts, the traditional mechanism for EPA cardioprotection.
Alternatively, we found that Ffar4 is expressed in the heart, and Ffar4 in cardiac fibroblasts in vitro was
sufficient and necessary to prevent TGFb1-­induced fibrosis. Thus, we hypothesized that EPA-­Ffar4 signaling is
necessary for EPA cardioprotection. However, we were surprised to find that Ffar4 also has w3-­independent
effects. In mice with systemic deletion of Ffar4 (Ffar4KO) on a standard diet, we found that TAC worsens
remodeling, but without exaggerated fibrosis, highlighting the role of Ffar4 in cardiac myocytes. In myocytes,
we found that Ffar4 was necessary for the expression of cardioprotective inflammatory genes and activation of
phospholipase A2 (PLA2). In humans, we found that Ffar4 expression is decreased in human HF, and Ffar4
polymorphisms are associated with contractile dysfunction in Framingham Offspring. Here, we propose a novel
paradigm where fatty acids function as signaling molecules to maintain cardiac homeostasis. We hypothesize
that in cardiac myocytes, Ffar4 functions as an w3-­independent cardioprotective, fatty acid nutrient sensor, and
that Ffar4 is necessary for EPA cardioprotection. We propose four aims. 1) To determine if cardiac myocyte
Ffar4 is necessary to protect against ischemia, cardiac myocyte-­specific Ffar4KO mice (CM-­Ffar4KO) will be
subjected to ischemia-­reperfusion (I/R) injury, and we hypothesize worse outcomes in the CM-­Ffar4KO. 2) To
define cardioprotective Ffar4 signaling mechanisms, following I/R injury in CM-­Ffar4KO mice and in hypoxia in
cultured myocytes, we will measure cell death, inflammatory cytokines, PLA2-­induced oxylipins, and how this
affects macrophage recruitment. 3) To determine if Ffar4 is necessary for EPA cardioprotection, CM-­Ffar4KO
on an EPA-­diet will be subjected to I/R injury, and we hypothesize EPA will fail to attenuate remodeling in the
CM-­Ffar4KO. 4) To determine the therapeutic potential of Ffar4, wild-­type mice subjected to I/R injury will
treated with the Ffar4 agonist TUG-­891 post-­MI. In humans, we will test for associations between Ffar4
polymorphisms and CVD in clinical cohorts. Although more patients survive MI, post-­MI HF is rising. Here, we
propose Ffar4 as 1) a novel cardioprotective, fatty acid nutrient sensor, 2) a potential therapeutic target to
attenuate post-­MI remodeling, and 3) the mechanistic basis for EPA cardioprotection.

Public health relevance
Coronary heart disease (CHD), leading to myocardial infarction (MI) and post- MI heart failure (HF), is a major cause of morbidity and mortality in the US. w3- polyunsaturated fatty acids, like eicosapentaenoic acid (EPA), improve outcomes in CHD and HF. Free fatty acid receptor 4 (Ffar4) is a G- protein coupled receptor for long- chain fatty acids including omega- 3 fatty acids. In the heart, our data suggest that Ffar4 has a dual role as an omega- 3- independent, fatty acid nutrient sensor, and the mechanistic basis for EPA cardioprotection.